8/11 Targeting Anti-inflammatory Gene Expression in Binge-like Drinking

Project Summary
High Drinking in the Dark (HDID) mice have been selectively bred to drink to intoxication. HDID mice are
genetically distinct and represent a unique genotype for drug screening. Many of the compounds that reduce
drinking in other strains (e.g., C57BL/6J) do not reduce drinking in HDID mice, and also fail to reduce drinking
in humans. Many INIA-Neuroimmune studies have found that alcohol alters inflammatory signaling. We
employed a rigorous approach for testing whether several compounds targeting immune signaling could
reduce binge-like drinking in HDID mice. To date, 14 out of 28 compounds tested in HDID mice were able to
reduce binge-like drinking in HDID mice. Apremilast, a phosphodiesterase type 4 inhibitor and our most
promising clinical target, and other compounds that reduced binge-like drinking have one thing in common -
they increase anti-inflammatory (e.g. IL-10) signaling. These results offer a broadly unifying hypothesis for
more mechanistic experiments to investigate how the balance of pro- and anti-inflammatory signaling regulates
binge-like drinking in HDID mice. Here, we study this mechanism in the context of initiation of binge-like
drinking, and determine whether this framework holds true under chronic binge drinking conditions. An
overarching goal of this proposal is to identify and target anti-inflammatory signatures to reduce drinking and
restore alcohol-induced changes in anti- and pro-inflammatory signaling in the brain. Specfic Aim 1 tests
whether specific inflammatory signaling pathways contribute to binge-like drinking in iHDID mice using a
combination of complementary molecular, genetic, pharmacological, and behavioral approaches in
collaboration with INIA-N PIs Roberto, Mangieri, Bilbo, and Lasek. Specific Aim 2 tests whether chronic binge-
like drinking is accompanied and/or regulated by anti-inflammatory gene expression in iHDID-1 mice. Aim 2 will
employ informatics approaches to identify compounds for behavioral and molecular studies in collaboration
with INIA-N PI Mayfield. This project also collaborates with INIA-Stress PIs Vazey/Mooreman and
Becker/Lopez to test the effects of promising compounds on other behaviors, and shares the HDID and HS/Npt
mouse lines as unique resources developed and maintained under this award with investigators nationwide.

Public health relevance
Project Narrative Apremilast, a phosphodiesterase type 4 inhibitor and our most promising clinical target for reducing harmful alcohol drinking, has been shown to increase levels of the anti-inflammatory protein, interleukin 10, in the periphery. We investigate how anti-inflammatory signaling in the brain regulates binge-like drinking in mice that have been selectively bred to drink to intoxication. An overarching goal of this proposal is to identify and target anti-inflammatory processes in the brain to reduce drinking and restore alcohol-induced changes in anti- and pro-inflammatory signaling in the brain.